2025 Artificial Molecular Switches and Motors Gordon Research Conference and Gordon Research Seminar

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Project Summary
The objective of the 2025 Artificial Molecular Switches and Motors Gordon Research Conference (GRC) is to foster innovation and collaboration to advance molecular machines capable of sensing, computing, and actuating at the molecular scale. This year’s focus will follow the theme, "Molecular Machines in Action," which emphasizes the transformative potential of these systems for human health and other applications. This interdisciplinary event brings together bioengineers, organic chemists, physicists, bioelectronics experts, soft robotic scientists, and others to promote idea exchanges and lead to groundbreaking biomedical advancements. Addressing the critical need to understand and utilize molecular machines for health applications, the conference will cover diagnostics, drug delivery, cellular surgery, and smart therapeutic devices. By convening experts and emerging researchers, the event aims to accelerate the translation of these technologies from lab to clinic, enhancing scientific knowledge and clinical applications. The conference aligns with the National Institute of Biomedical Imaging and Bioengineering (NIBIB)'s mission to advance biomedical technologies for human health.
The GRC format encourages deep scientific exchange through formal presentations, poster sessions, and informal discussions, facilitating collaboration and new ideas. Key topics include photopharmacology, soft robotics, wearable electronics, DNA nanorobotics, artificial muscles, and smart tattoos. Invited speakers, such as Dr. Dirk Trauner (photopharmacology) and Dr. William Shih (DNA nanotechnology), and many others will provide insights into the latest advancements and future directions in molecular machines. The associated Gordon Research Seminar (GRS) will offer graduate students and postdoctoral researchers a platform to present their work and network before the GRC begins. By showcasing cutting-edge research and fostering interdisciplinary dialogue, these events will drive innovation, support early career researchers, and advance novel biomedical imaging and bioengineering technologies. The conference will significantly impact the scientific community by promoting collaboration, new concepts, methods, and technologies aimed at improving human health.

Public health relevance
By accelerating the application of new molecular switches, motors, and machines into biomedical application, the conference aims to contribute to developing new paradigms for the diagnosis, treatment, and prevention of diseases, thereby enhancing public health outcomes. Topics of public health relevance include wearable sensors and smart tattoos for health monitoring, photopharmacology to treat blindness and other conditions, DNA nanotechnology for drug delivery, therapeutic applications of molecular motors, and many others.